Task Order #1: Centralized Chemopreventive Agent Repository and Chemistry Support

This contract is to continue a well-established Repository program within the Division of Cancer Prevention (DCP) at the National Cancer Institute (NCI). The Contractor shall maintain a centralized source of agents and development services necessary to support chemoprevention studies for effective medical interventions in the prevention or reduction of cancer. The repository provides important logistic organization for the acquisition, tracking, storage, maintenance, testing, quality control, and distribution of investigational agents.